Mount Sinai Regional Drug Induced Liver Injury Network Site

The Drug Induced Liver Injury Network (DILIN), sponsored by NIDDK was established in 2003 to identify cases
of DILI across a diverse demographic and geographic spectrum. Mount Sinai has been an integral part of the
DILIN since 2013 and helped the network increase recruitment such that patient accrual now exceeds
expectations. The current 6 clinical sites have performed very well, with Mount Sinai among the leading
enrolling sites, particularly for acute DILI cases. The integration of several new hospitals to the Mount Sinai
Health System and formation of a Liver Institute to organize hepatology care across the health system will
likely result in an increase in enrollment from the Mount Sinai DILIN site with added ethnic diversity. As a
whole, the DILIN is well positioned to embark on important goals: continuing to recruit patients early in the
course of illness to identify DILI biomarkers; increase the racial/ethnic diversity of patients in the prospective
cohort by focused recruitment in urban areas; enrollment of herbal and dietary supplement (HDS) cases along
with analysis of HDS products collected in the repository; setting up systems for early detection of drugs or
HDS associated with DILI to assist regulatory authorities; and continuing to provide accurate clinical
information about DILI through published literature and support for the Livertox website. The Specific Aims for
the Mount Sinai site are as follows: 1) To enroll adults and children with DILI in the current DILIN prospective
and retrospective databases; 2) To specifically enroll patients early in the course of suspected DILI; 3) To
enrich the current DILIN prospective and retrospective databases with patients of non-Caucasian ethnicity; 4)
To evaluate serum and genetic biomarkers for chemotherapy-induced liver injury and determine if melatonin
pretreatment prevents chemotherapy-induced liver injury; and 5) To rapidly identify newly approved
prescription medications and new HDS formulations that cause unexpected concentrations of DILI cases.

Public health relevance
Unexpected as there Network and about ethnic drug-induced liver injury (DILI) from prescription and over the counter rugs as well herbal and dietary supplements is a common problem which can lead to serious illness and is o treatment except for stopping the offending agent in a timely manner. The US DILI enrolls patients with DILI in order to better understand how to make a diagnosis, how why the injury occurs, which types of people are more at risk and to educate the public this illness Mount Sinai is part of the DILI Network and is particularly interested in DILI in minorities and in the evaluation and prevention of DILI due to drugs that treat cancer. d n .